Piloting Deposit Contracts to Increase Accessibility of a Contingency Management Intervention to Reduce Problematic Drinking

Project Summary/Abstract
Problem drinking is a leading cause of preventable morbidity and mortality in the US, with high economic
cost; however, effective interventions often remain inaccessible. In response, this R21 application proposes to
translate our previously developed incentive-based intervention into a sustainable, easily accessible
intervention using remote alcohol monitoring and deposit contracts, targeting individuals who would not be
reached by more traditional forms of treatment due to barriers such as time constraints, attitudes, and stigma.
Incentive-based interventions are highly effective and overcome many of these barriers and can be
attractive to people not seeking more formal treatment for their substance abuse. Previously we demonstrated
that one such incentive-based intervention (i.e., contingency management) providing weekly payments based
on remote alcohol monitoring effectively reduces dangerous drinking. However, contingency management
interventions like ours remain largely inaccessible due three widely held concerns: (1) objectively detecting
alcohol consumption is difficult (which we have overcome with remote alcohol monitoring); (2) providing incen-
tives makes contingency management expensive; and (3) contingency management is viewed by some as
ethically questionable, because it rewards clients for not engaging in behaviors they should not pursue
anyway. To alleviate these concerns, we propose using deposit contracts. With deposit contracts: (a)
individuals invest their own money, which is earned back if a specified goal (or contingency) is met; and (b)
remote alcohol monitoring and electronic payment, obviate frequent clinic visits. Like contingency man-
agement, deposit contracts provide incentives for the absence of problem drinking, but incentives come from
participants themselves. Deposit contracts are less expensive than contingency management and reduce eth-
ical objections by having participants reward themselves for reducing problematic drinking.
This proposed pilot study will explore the feasibility of deposit contracts by recruiting heavy-drinking
individuals into a deposit contract intervention aimed at reducing their problem drinking (Aim 1) and develop
evidence of deposit contract effectiveness and cost-neutrality (Aim 2). Such an intervention would reduce
barriers that limit accessibility (such as cost, time, and travel) and ethical concerns. This project is timely,
since over a dozen companies are developing “Fitbit”-style alcohol monitoring devices, many of which are now
undergoing pilot and validation work in preparation for consumer use (we are a site independently validating
one such device). The work proposed will demonstrate feasibility, provide initial evidence of effectiveness, and
lay the groundwork for a much larger study of an intervention that could be made widely accessible for
reducing problem drinking in a novel and sustainable manner.

Public health relevance
PROJECT NARRATIVE Public Health Significance: Excessive alcohol consumption poses a significant public health concern due to the negative health and societal consequences associated with chronic overconsumption. This project will adapt our effective intervention (i.e., a contingency-management procedure) using remote alcohol monitoring into a more sustainable approach (i.e., deposit contract) that could be made more widely available. The proposed study will also provide evidence needed to establish an intervention for treatment-seeking individuals who face barriers associated with cost and accessibility.